TRAINING IN PULMONARY IMMUNOLOGY

Abstract This is a competing continuation to support six post-doctoral positions to provide rigorous research training for pulmonary physicians at the fellowship level and Ph.D. recipients with interests in lung disease. The ultimate goal is to develop pulmonary scientists in either basic or translational research who can successfully continue their careers in academics or the biomedical industry. After completion of clinical or Ph.D. training, all trainees begin a two year (minimum) period of virtually uninterrupted time for research training. One of two tracks can be chosen. For those choosing a basic science pathway, the key training activities will be mentored time in a basic research laboratory, supplemented by attendance at research conferences and seminars and a variety of course work. For those choosing the translational pathway, the key training activities will be mentored time conducting a clinical research project coupled with a series of classes focused on gaining clinical trial skills. Translational applicants will be closely tethered to a basic science lab, although they will not be required to complete a laboratory project. Training will be supplemented by attendance at research conferences and seminars. Select trainees will be provided with a third year of research training. All trainees selected for this training grant are assigned a mentoring committee, similar to a graduate student thesis committee, that carefully tracks each trainee's progress throughout their research training and transition to faculty status or other research job opportunities. The program will continue to foster broad multidisciplinary approaches to research with strong ties to trainers outside of the Pulmonary Division. This will be strengthened by a newly established “Institute for Lung Biology” with accompanying unified space for lung research. Changes in this renewal application are addition of selected faculty with unique training expertise, increased availability of a Master in Translational Research degree, and an enlargement of the applicant pool by including qualified Pediatric Pulmonary Fellows from Children's Hospital of Philadelphia. Continued efforts to increase minority recruitment are also planned.

Public health relevance
Narrative This is a competing continuation to support six post-doctoral positions to provide rigorous research training for pulmonary physicians at the fellowship level and Ph.D. recipients with interests in lung disease. The ultimate goal is to develop pulmonary scientists in either basic or clinical research who can successfully continue their careers in academics or the biomedical industry. Trainees can focus on basic or translational training.